A DOSE RANGE FINDING STUDY OF INTRAVENOUS 349U85 HCL IN CONGESTIVE HEART FAILURE

This study is to evaluate the safety and specific effects on heart function with increasing doses of 349u85 HCL intravenously. The secondary goal will characterize the excretion of 349u85 and its metabolites.